Metabolic and Neurocognitive Impacts of Military-Associated Toxicant Exposures

Arsenic is a widespread environmental toxicant contaminating the drinking water of over 100 million
individuals globally. Importantly, veterans experience additional exposures from their service, including
historical chemical weapons use, contaminated military bases, ordinance disposal, burn pits, oil fires, and the
extensive use of arsenic-based pesticides (Agent Blue) in Vietnam. Arsenic is associated with multiple
conditions enriched in the veteran population, including neurocognitive disorders like anxiety,
depression, and PTSD; however, the full impact of arsenic exposure on veterans’ health remains grossly
underappreciated. Thus, understanding the links between arsenic and veterans’ health as well as the
mechanisms by which arsenic promotes disease development may illuminate novel therapeutic approaches to
reduce the considerable burden of mental health disorders among America’s veterans. Our data indicate that
one mechanism of arsenic-induced neurocognitive dysfunction is via depletion of brain
docosahexaenoic acid (DHA), an essential fatty acid critical for normal brain development and function.
Indeed, arsenic exposure and low DHA consumption are both independently associated with
neuropsychiatric disorders. In addition, mechanistic studies show that arsenic and DHA exert opposing
actions on multiple pathways regulating neurocognitive function. Because of DHA’s central role in neuronal
health, approaches for enhancing brain DHA levels are needed; however, traditional DHA supplements fail
to deliver DHA across the blood brain barrier (BBB). In contrast, our novel DHA delivery approach using
lysophosphatidylcholine-linked DHA (LPC-DHA) exploits a unique transporter at the BBB (Mfsd2a),
allowing for brain DHA enrichment and improvements in neurocognition. Whether LPC-DHA can address
arsenic neurotoxicity arising from military service is unknown. In Specific Aim 1, we will use a mouse model to
characterize the impact of military-associated arsenic exposure on neurocognitive function across domains
of learning/memory and anxiety/depression, with a focus on behaviors regulated by the amygdala,
hippocampus, and prefrontal cortex. We will also examine critical mechanisms of arsenic neurotoxicity.
Finally, we will assess the capacity of LPC-DHA to rescue arsenic-induced neurobehavioral abnormalities.
Evidence for such rescue would suggest that LPC-DHA may be a novel treatment for mitigating historical
arsenic exposure, such as among Vietnam veterans exposed to Agent Blue. Better than treatment, however,
would be prevention. Since serving in combat areas increases exposures to multiple environmental toxicants
that induce oxidative stress and may adversely affect mental health through brain DHA depletion, it is critical to
know whether service members can be protected from the adverse effects of these exposures. In Specific
Aim 2, we will interrogate the supposition that LPC-DHA supplementation during exposure prevents arsenic-
induced neurocognitive dysfunction, while characterizing the mechanistic pathways amenable to protection.
Evidence of such protection would suggest that LPC-DHA may be a nutraceutical with neuroprotectant effects
worth deploying with troops to protect their long-term neurological health. Collectively, these studies will
illuminate the neurocognitive consequences of arsenic exposure, clarify arsenic’s underlying
mechanisms of neurotoxicity, and provide new insights into intervention strategies to reduce the
devastating impact of this common environmental toxicant on veterans’ health.

Public health relevance
For over 100 years, U.S. military personnel have been exposed to arsenic, a common environmental contaminant associated with neurocognitive disorders. One potential mechanism linking arsenic to neurocognitive dysfunction is through depletion of the essential fatty acid docosahexaenoic acid (DHA), which is critical for both brain development and function. This project investigates how arsenic-mediated disruption of DHA contributes to neurocognitive dysfunction in mice while exploring the therapeutic potential of targeted delivery of DHA to the brain as a means of addressing neurocognitive disorders in arsenic-exposed veterans.